The adaptor protein Crk in immune responses

Project Summary:
This proposal is a renewal application of R01 (AI130197). In the previous funding cycle, we sought to identify
the mechanism(s) by which the small adaptor protein Crk controls NK cell activation and inhibition, using
human NK cells and NK cell-specific conditional knockout mice. We found that Crk phosphorylation plays a key
role in function and that Crk haploinsufficiency leads to NK cell deficits and impaired integrin signaling.
Importantly, we identified new small molecule inhibitors of pCrk (Patent #: 63/305,354). In the proposed
renewal, we use this new tool to further dissect Crk’s ability to integrate activating and inhibitory input at the
immune synapse (IS) of both NK and T cells in a variety of relevant settings: in high-resolution live human
primary cell imaging assays, in human Crk haploinsufficiency, and in triple negative breast cancer (TNBC). We
test our central hypothesis that Crk functions as a master regulatory switch, fine-tuning activating and
inhibitory influences via interactions with downstream molecules and the actin cytoskeleton, and propose the
new hypothesis that pCrk inhibition can restore exhausted immune responses in cancer via novel signaling
pathways. Guided by strong preliminary data, we propose three Specific Aims: 1) How does Crk function as
a master regulatory switch to control NK cell function? Here, we use cutting-edge imaging systems, lipid
bilayers, live human primary cells, RNA-Seq, and our new CrkL inhibitors to determine where Crk, pCrk, and
their upstream and downstream partners localize in the cytotoxic, inhibitory, and exhausted IS, and how pCrk
inhibitors influence NK signaling in healthy and exhausted NK cells. 2) How does Crk influence immune
function and integrin signaling in pDGS T cells? Our previous program showed that NK cells from patients
with pDGS – a common genetic syndrome resulting from haploinsufficiency of CrkL-containing locus 22q11 –
exhibit functional NK cell deficiencies, as well as defective integrin activation at the IS. We expand these
studies to T cells, using primary pDGS patient cells and integrin conformation-specific antibodies to assess
how Crk functions as a two-way regulatory switch for CTL function. We present data that haploinsufficiency of
CRKL results in functional T cell deficits, and examine integrin signaling, T cell function, and IS quality with an
eye towards clinical application of small molecule LFA-1 agonists to restore pDGS-related functional immune
cell deficiencies. 3) Discover the role of pCrkL inhibitors in cancer immunotherapy. Our preliminary data
show that pCrk inhibitors significantly inhibit tumor growth, restore cytotoxicity of inhibitor receptor-dominant
immune cells, and enhance survival. We hypothesize that pCrk inhibitor-mediated solid tumor suppression
results from both direct tumor killing and restoration of exhausted immune cell function. In Aim 3, we use a
battery of TNBC mouse models to elucidate Crk’s molecular mechanisms in solid tumors, testing the impact of
Crk inhibition on tumor growth and cell death, immune cell function in the tumor microenvironment, and
metastasis. Our long-term goal is to develop new treatments for human immunodeficiencies and cancer.

Public health relevance
Project Narrative: In this grant renewal, we investigate how the small adaptor protein Crk and its phosphorylation function as a molecular switch to turn immune cell function on and off. We use newly identified pCrk inhibitors as a tool to dissect out Crk’s ability to integrate activating and inhibitory immune cell influences in a variety of clinically relevant settings: live human immune cells, a common human immunodeficiency (partial DiGeorge syndrome, pDGS), and mouse models of breast cancer. Outcomes will result in a new view of Crk in immune responses, tumor suppression, and immune cell exhaustion, and will set the stage for immune restoration in immunodeficiency and cancer.